Influence of Hydraulic Resistance on the Osmotic Engine Model of Cell Migration

Project Summary – no change from awarded project.

Public health relevance
Project Narrative – no change from awarded project.